Behavioral and physiological linkage in people with frontotemporal dementia and spousal caregivers

PROJECT SUMMARY
This Pathway to Independence Award will equip the candidate with the key skills to study interpersonal
connectedness by examining behavioral and physiological linkage (e.g., how closely people’s heart rates and
emotional behaviors are synchronized) in individuals with frontotemporal dementia (FTD) and their spousal
caregivers (CGs). FTD is associated with profound neurodegeneration in the frontal and temporal regions of the
brain and severe socioemotional symptoms (e.g., apathy, disinhibition) that are difficult not only for the person
with dementia (PWD) but also for the CG. Caring for a loved one with FTD can be a meaningful part of family
life; however, disruptive symptoms can produce deleterious effects and undermine CGs’ health and well-being.
Given the strong associations established between close interpersonal connectedness and health/well-being,
the candidate plans to take novel steps to examine (a) how interpersonal connectedness of the PWD and CG is
altered in FTD (Aims 1 and 3), and (b) how altered PWD-CG connectedness provides a bridge that links
PWD’s socioemotional symptoms to CG’s health declines (Aim 2). Importantly, the candidate plans to study
PWD-CG connectedness by assessing both behavioral and physiological indicators of PWD-CG
connectedness. This novel approach will provide more objective, less cognitive-demanding, and more
continuous measures for PWD-CG connectedness, as compared to single self-report measures that have
typically been used in past research. The candidate also plans to develop the optimal methodological approach
for quantifying PWD-CG connectedness in both laboratory and naturalistic settings (e.g., identify the measure of
physiological linkage that best predicts poor CG health; Aim 4). The candidate has received solid training in
cognitive neuroscience and has a strong track record using integrative methods to study emotion and social
functioning in healthy and clinical populations. To support the candidate in conducting the proposed research,
training in 3 areas is planned: (a) dyadic behavioral and physiological time series data analysis, (b) diagnosis
and clinical assessment of FTD, and (c) dementia caregiving. Training will occur under the mentorship of
renowned experts in each field (including a clinical psychologist, a behavioral neurologist, and a nurse
specialist). The training environment at the Department of Psychology, University of California, Berkeley
(primary), and the Memory and Aging Center, University of California, San Francisco (secondary), will be ideal
for the proposed training and research, as well as for developing the candidate’s professional skills. Together,
the award will help the candidate launch his research career as an independent scientist with unique expertise
in dyadic emotion and psychophysiology, neurodegenerative disease, and caregiving. The proposed research
will help advance the understanding of the pathways through which FTD yields collateral damage on CGs, and
provide a novel, objective, continuous, and potentially portable measure to quantify PWD-CG connectedness
for future research and clinical use.

Public health relevance
PROJECT NARRATIVE Close interpersonal connectedness to others, particularly loved ones, is critical for health and well-being. The proposed project will examine how interpersonal connectedness between patients and spousal caregivers changes in frontotemporal dementia, and how these changes in connectedness form a bridge that links a patient’s disruptive symptoms to problems in a caregiver’s health. Patient-caregiver connectedness will be studied using a novel, objective, and less cognitively-demanding approach by measuring how closely their behavior and physiological responses are “linked” during dyadic interactions.